Wake Forest Clinical and Translational Science Award

Contact PD/PI: MCCLAIN, DONALD A.
Summary: Overall
When the Wake Forest (WF) Clinical and Translational Science Institute (CTSI) joined the CTSA consortium in
August 2015, our goal was to use our resources to catalyze WF’s transformation into an exemplary Learning
Health System in which “science, informatics, incentives, and culture are aligned for continuous improvement
and innovation, with best practices seamlessly embedded in the delivery process and new knowledge captured
as an integral by-product of the delivery experience.” We seek to extend this framework by integrating traditional
academic goals of T0 – T4 discovery, translation, and scholarship to form a new vision—the Academic Learning
Health System (aLHS). In our initial 3 years of funding, we have progressed towards our goal, establishing an
integrated research governance model, with the CTSI at its core, to realize efficiencies and address roadblocks
that hamper translational progress. We established Translational Catalysts to link the academic and clinical
enterprises and designed training programs to develop the skills our workforce needs to make the aLHS a reality.
We developed foundational informatics infrastructures essential to learning and growing, engaged communities
and stakeholders to integrate diverse perspectives into the fabric of our aLHS, and created a milieu for nurturing
innovative translational methods. We became a valued member of the CTSA national network, actively
collaborating with 20 CTSA hubs, and shared our world-class nonhuman primate models with the consortium.
With these successes, we turn to the next 5 years with strong assets in leadership, structure, scholarship, and
culture that uniquely position us to realize the aLHS ideal. We will fully integrate our new Translational Catalysts
– biomedical informatics, implementation science, precision medicine, healthcare innovation, and clinical trials –
and use them, along with incentives for academic engagement, to mobilize our growing clinical network. We will
develop, implement, and broadly disseminate improved methods and processes that will increase the efficiency,
safety, and reproducibility of preclinical and clinical science. We will partner with our community to integrate
special populations, and support health research across the lifespan. We will train our workforce for new roles,
especially in team environments, with new training programs (e.g., TL1 aLHS Scholars Program, the Learning
TREE online educational platform for individualized learning, Research-in-Action) and broaden our highly
successful KL2 training for early-career faculty. We will serve as a hub for biomedical informatics, accelerating
progress by enhancing existing resources, promoting collaboration and data sharing, and building new capacity.
We will remain committed to inclusiveness, mutual respect, and multiple perspectives to act as a catalyst for
change and healthy equity. We will further extend the reach of the aLHS into the communities served by our
expanding health system and will broaden our collaborations with other CTSA hubs to share best practices and
export the aLHS model – all guided by our ultimate goal of improving the health of our region and nation.
Page 243
Project Summary/Abstract
Contact PD/PI: MCCLAIN, DONALD A.
Narrative: Overall
The Wake Forest Clinical and Translational Science Institute seeks to become the model of an integrated
Academic Learning Health System in which we develop, implement, offer tailored training tools, and broadly
disseminate improved methods and processes to increase the efficiency, safety, and reproducibility of preclinical
and clinical science. We will build on our achievements to fully integrate our new Translational Catalysts –
biomedical informatics, implementation science, precision medicine, healthcare innovation and clinical trials –
and use them to develop and test initiatives, deploying research findings across our growing clinical network.
We will remain committed to training the next generation of scientists and leaders and will partner with our
community and CTSA hubs to integrate special populations and support research across the lifespan to extend
the benefits of our progress to the widest possible audience.
Page 244

Public health relevance
The Wake Forest Clinical and Translational Science Institute seeks to become the model of an integrated Academic Learning Health System in which we develop, implement, offer tailored training tools, and broadly disseminate improved methods and processes to increase the efficiency, safety, and reproducibility of preclinical and clinical science. We will build on our achievements to fully integrate our new Translational Catalysts – biomedical informatics, implementation science, precision medicine, healthcare innovation and clinical trials – and use them to develop and test initiatives, deploying research findings across our growing clinical network. We will remain committed to training the next generation of scientists and leaders and will partner with our community and CTSA hubs to integrate special populations and support research across the lifespan to extend the benefits of our progress to the widest possible audience.